Heme-Dependent Chemistry in Tyrosine Oxidation

Heme-Dependent Chemistry in Aromatic Oxidation
Abstract
Heme-containing enzymes are ubiquitous, contributing to various processes and catalyzing a vast array of
oxidative chemistries. Histidine-ligated heme enzymes, such as the heme-dependent aromatic oxygenase
(HDAO) superfamily, can use either molecular oxygen or hydrogen peroxide to oxidize their substrates. What is
currently not understood are the molecular factors that engender these enzymes with their respective specificities,
i.e., after generation of the critical active oxidant, how is a single reaction type catalyzed? The answer to this
question will broaden our fundamental understanding of enzyme catalysis, de novo enzyme design, and protein
engineering. This application focuses on the structural and mechanistic characterization of three aromatic-
oxidizing enzymes of the HDAO superfamily involved in natural product and antimicrobial drug biosynthesis,
including antibiotics with a pyrroline moiety or a core quinone structure. These enzymes play essential roles in
the biosynthetic pathway of secondary metabolites found in many biologically active natural products and
pharmaceutical lead compounds. Our primary goal is to understand the key factors that govern their
hydroxylation mechanisms and their differing strategies to form oxidizing intermediates with these enzymes. We
have utilized a broad spectrum of approaches to probe the intricate molecular details of these enzyme
mechanisms using noncanonical amino acids, substrate analogs, time-resolved UV-vis and EPR spectroscopies,
kinetics, and isotope-labeling studies, and we have been successful in trapping on-pathway reaction
intermediates in crystallo. The proposed work will test our hypotheses regarding i) how the heme-based oxidant
is generated, ii) how oxygen is directed to the substrate, and iii) unravel the structural factors that affect catalysis.
The outcome of the proposed studies is an in-depth understanding of these three related catalytic systems to
aid the development of scaffolds for rational drug design and discovery processes.

Public health relevance
Narrative This project will investigate the chemistries of a group of enzymes involved in the biosynthesis of crucial building blocks of natural products with antibiotic and anticancer properties. The biochemistry of secondary metabolism learned from this study will deepen the understanding of synthetic pathways and regulation toward bioactive molecules. The knowledge procured will also help design and expand the repertoire of chemical compounds with desired biological activities beneficial for human health.